Core C

Project Summary/Abstract- Core C
The in vitro Electrophysiology Core (Core C) will provide services for in vitro
electrophysiological studies using novel tools such as optogenetics, designer receptors
exclusively activated by designer drugs (DREADDs) and in vitro GCaMP6 calcium
imaging. We will prepare brain slices, conduct patch-clamp recordings, optimize the
protocols for the optogenetic and chemogenetic experiments, perform Ca2+ imaging
studies in in vitro slices, and conduct channelrhodopsin2 (ChR2)-assisted circuit
mapping (CRACM). The Core will also perform histology of the recorded slices, and
analyze the associated data. Project 1 (Saper), Project 2 (Scammell), Project 3 (Fuller)
and Project 4 (Vanderhost and Dymecki) will use this Core facility. These projects are
not equipped to conduct in vitro electrophysiology recordings and there are no
institutional resources that can provide this service. The Projects will benefit from the
expertise and shared resources of the Core.